TOF-PET with high-efficiency TlCl crystals

Summary
Time-of-flight positron emission tomography is a very effective nuclear imaging modality for the diagnosis and
staging of a range of pathologies such as cancer, cardiovascular diseases, or musculoskeletal disorders.
Commercial TOF-PET scanners currently employ lutetium-(yttrium)-oxyorthosilicate (L(Y)SO) crystal detectors
coupled to silicon photomultipliers (SiPMs) to achieve coincidence time resolutions (CTR) between 200-500 ps
full width at half maximum (FWHM).
High production costs of L(Y)SO crystals and their intrinsic radiation background are currently hindering the
evolution and spread of very promising TOF-PET modalities such as long axial field-of-view (LA-FOV) scanners
or studies involving very low doses such as cell tracking or imaging with theranostic agents. New scintillator
materials with lower production cost, radiation background-free, and with TOF-level timing accuracy are needed.
We propose to use thallium chloride (TlCl) as a scintillator material for TOF-PET. TlCl is a material with a simple
cubic structure that allows for a relatively easy and flexible doping process. Preliminary data obtained with TlCl
crystals doped with beryllium (Be) and indium (I) show a very fast scintillation component of ~10 ns that has a
high potential for very accurate timing measurements. TlCl has a greater detection efficiency than LYSO or even
bismuth germanate (BGO) for 511 keV gammas, is background radiation-free, and its estimated production cost
is 1/3 of L(Y)SO based on its low melting point of 430C (compared to 2050C for L(Y)SO) and simple lattice
structure. Moreover, unlike BGO, TlCl uniquely combines a very fast scintillation process with a high Cherenkov
generation yield to further boost timing potential.
We aim to prove the feasibility of using TlCl detectors for TOF-PET by combining expertise in crystal growth,
simulation of light generation and detection, and benchtop characterization. First, will study the effects of Be and
I as dopants in TlCl with the aim of further improve the scintillation properties observed in the preliminary data.
We will also optimize the surface treatment of TlCl to maximize the light extraction toward the photodetector.
Second, we will develop a simulation framework that allows us to guide the crystal development process and to
understand the fundamental timing limits of TlCl. Third, we will characterize individual TlCl crystals with different
choices of photodetectors to evaluate their timing and energy resolution accuracy. Results obtained with these
crystals will be used to tune and validate the simulation model as well. Finally, we will evaluate the performance
of TlCl detector blocks of 4x4 crystal elements. We will evaluate their timing resolution, depth-of-interaction
estimation accuracy, and quality of flood histograms.

Public health relevance
NARRATIVE Time of flight positron emission tomography (TOF-PET) is a very effective nuclear medicine technique to diagnose cancer, cardiovascular diseases, and musculoskeletal disorders. Novel modalities of TOF-PET have emerged during the last years, such as long axial field of view (LA- FOV) TOF-PET or studies with very low dose uptake, but state-of-the-art detectors used in TOF- PET are hindering their progression due to the elevated production cost and intrinsic physical properties. In this project, we will evaluate the feasibility of using a new detector material, thallium chloride, as it offers a low production cost and very attractive physical properties that can allow for a practical adoption and spread of the most recent TOF-PET techniques.